Characterization of HIO-2, a tumor-produced protein that inhibits therapeutic antibody-mediated cellular cytotoxicity via Fc Receptor (CD16a) blockade

The field involving antibody-dependent cellular cytotoxicity (ADCC) and complement-mediate cytotoxicity
(CDC) activities mediated by therapeutic antibodies is referred to as humoral immuno-oncology (HIO).
Tumor-produced factors that may have immunosuppressive effects on ADCC and CDC activities are called HIO
factors. We screened several HIO factor candidates (HIO-Xs) based on their production/secretion by various
tumor types. HIO-Xs can be serum biomarkers representing proteins shed by the tumor. Using a set of
optimized HIO assays which we developed, two new HIO factors were found to be immunosuppressive and
were named HIO-2 and HIO-3. The focus of this proposal is on the characterization of HIO-2.
HIO-2 is a mucin protein produced and over-expressed in breast, lung, ovarian, endometrial, bladder, and
gastrointestinal cancers. HIO-2 is present in a membrane-bound form as well as a soluble/shed form.
Preliminary data suggest that soluble HIO-2 binds to CD16a/Fc gamma receptor, blocking antibody binding,
and ultimately inhibiting ADCC activity of trastuzumab and pertuzumab due to reduced antibody/Fc receptor
engagement. HIO-2 blockade of CD16a function creates an immunosuppressed tumor microenvironment
potentially impacting therapeutic antibodies activity. In fact, elevated serum levels of HIO-2 correlate with
worse progression-free survival after treatment with trastuzumab. The goal of our program is to generate and
test compounds that can overcome immunosuppression mediated by HIO-2. This proposal focuses on the
initial tasks of an overarching approach aimed at bringing HIO-2 antagonists into clinical testing after
appropriate discovery and preclinical validation. In Year 1, we will be answering the question: Can a
pharmaceutically viable HIO-2 antagonist candidate be developed? In Aim 1, effort will be allocated to
defining the HIO-2/CD16a binding interface which will guide future structure-activity relationship analyses of
HIO-2 antagonists. In Aim 2, an expanded natural compound library will be screened to identify additional
HIO-2 antagonist candidates having improved activity profile. Lead candidates and their analogs will be tested
in vitro for potential toxicity and metabolic stability. In Year 2, we will be answering the question: Can HIO-2
antagonist enhance the anti-tumor effect mediated by therapeutic antibodies in vivo? In Aim 3, the current
lead HIO-2 antagonist, or any better lead(s) identified in Aim 2, will be assessed for oral availability in mice
and compared to intravenous administration. The maximum tolerated dose of the lead antagonist will be
assessed for the selected route (PO or i.v.). Finally, the lead HIO-2 antagonist will be tested alone and in
combination with trastuzumab using a patient-derived xenograft (PDX) model of breast cancer, wherein this
PDX has high levels of HER2 expression, high levels of HIO-2, and is somewhat resistant to trastuzumab
anti-tumor effect. The benefit of a HIO-2 antagonist strategy extends to current and future therapeutic
antibodies with immune effector function, including rituximab, daratumumab, cetuximab, and others.

Public health relevance
We identified HIO-2, a protein shed by tumors that binds to CD16a/Fc gamma receptor, blocking antibody binding, and ultimately inhibiting ADCC activity of trastuzumab, pertuzumab, and other antibodies. The 3 aims proposed here will enable us to make progress towards supporting or refuting the hypothesis of HIO-2’s putative clinical relevance in immunosuppression. Aims include defining the HIO-2/CD16a binding interface, identification of HIO-2 antagonist candidates, and testing HIO-2 antagonists in animal models.